Characterizing Alzheimers Disease and Serious Mental Illness Co-Occurrence Among Nursing Home Residents and Relationship to Symptomatology and Care Practices

PROJECT SUMMARY/ABSTRACT
Individuals with Alzheimer’s disease and related dementias (ADRD) experience progressive cognitive decline
and behavioral and functional impairment. With disease progression, individuals with ADRD also experience
heightened risk for poor outcomes which often culminate in the need for skilled care provided in nursing homes
(NH); almost all individuals with ADRD will receive short- or long-term NH care at some point. While providing
high-quality, person-centered ADRD care is a national priority, progress toward this goal is limited in part by a
lack of understanding regarding the influence of major comorbidities on ADRD disease burden, care needs, and
symptoms. In particular, comorbid serious mental illness (SMI), which is common among individuals with ADRD,
remains understudied despite its impact on disease risk, burden, care needs, and symptomatology. Burden of
both ADRD and SMI is particularly high in NH settings. Understanding whether SMI plays an additive role in
shaping behavioral symptom presentation among individuals with ADRD, care needs (e.g. pain), and outcomes
(e.g. falls) can inform intervention targets and improve person-centered care across settings. Towards this end,
I propose a mixed methods sequential explanatory design to investigate the contribution of SMI to ADRD
symptoms, outcomes, and care interventions; domains informed by the Need-Driven, Dementia-Compromised
Behavior Model. I will utilize secondary data available through the Minimum Data Set 3.0 (MDS 3.0) (Aim 1/1A)
and conduct interviews with NH staff (Aim 2). My long-term goal is to establish a program of research designing
and delivering person-centered interventions for symptom management among adults with ADRD and complex
comorbidities. My short-term objective is to characterize ADRD/SMI’s relationship to shared and distinct
symptomology, outcomes, and care interventions; and implications for individuals with ADRD and provision of
person-centered care. Under Aim 1, I will describe patterns and characteristics of comorbid ADRD/SMI diagnosis
among NH residents using 2019 MDS 3.0 NH assessment data (N~500,000). Applying clustering techniques, I
will define underlying ADRD/SMI disease co-occurrences and their variation by demographic characteristics. I
will then evaluate how distinct ADRD/SMI comorbidities are associated with unique behavioral symptoms,
outcomes (e.g. falls, functional status) and care needs/interventions (e.g. medication use, restraint use) as
compared to ADRD alone (Aim 1A). Under Aim 2, I will explain and extend Aim1/1a findings by conducting
content analysis of interviews with NH staff (e.g. nurses, nursing assistants, social workers, providers) (N=30,
total) about their perceptions of ADRD/SMI comorbidities and care of residents with complex cognitive and
psychiatric care needs. Impact: Findings from the proposed study are responsive to ADRD research priorities
and will provide foundational data informing targets for person-centered care interventions for patients with
ADRD/SMI by illuminating the contributory role of SMI to ADRD symptoms and care. The training plan will
support my broader career goal of becoming a leading clinician scientist focused on aging and ADRD care.

Public health relevance
PROJECT NARRATIVE/RELEVANCE Delivery of high-quality care for the 5.8 million individuals living with Alzheimer’s disease and related dementias (ADRD) is a national priority that is hindered by our lack of understanding of the ways in which comorbidities such as serious mental illness (SMI) contribute to unique care needs, symptoms, and disease burden. The proposed project will use both national data and formal caregiver perspectives to characterize the impact of having both SMI and ADRD on symptoms, disease burden, and care. The findings will be used to identify possible targets for future development and testing of person-centered interventions that address these unique needs and improve outcomes for persons with ADRD.